Dissecting the Functional Role of Monocytes in B-cell Acute Lymphoblastic Leukemia Survival

Scientific Abstract
The bone marrow microenvironment most likely plays a significant role in promoting B-cell acute lymphoblastic
leukemia (B-ALL) survival, progression, and escape from treatment. Our preliminary studies utilized single-cell
profiling approaches to comprehensively map the primary human B-ALL bone marrow immune
microenvironment throughout three distinct stages of the disease: diagnosis, remission and relapse.
Importantly, we uncovered a role for leukemia-associated monocyte subpopulations in B-ALL survival,
demonstrating that monocyte abundance at diagnosis is predictive of pediatric and adult B-ALL patient
outcomes. Using a three-dimensional (3D) microfluidics-based organotypic device, we show that human B-ALL
blasts alter a vascularized microenvironment to promote monocytic differentiation and depletion of leukemia
associated myeloid cells in Ph+ B-ALL animal models leads to prolonged disease remission in vivo. This project
will determine the precise origins and function of nonclassical monocytes in supporting B-ALL survival and,
ultimately, target leukemia-supporting monocytes to enhance the efficacy of existing ALL therapy. To achieve
this, we will use two-photon live-imaging to assess nonclassical monocytes' behavior within the leukemic
niche. We will then take advantage of murine strains lacking nonclassical monocytes, as well as established
single-cell profiling approaches, to assess monocyte abundance's impact on the remodeling of a vascularized
leukemic niche in vivo. We will expand our flow cytometric analysis of large cohorts of primary pediatric B-ALL
patient samples to establish the association between monocyte abundance, monocyte differentiation state, and
patient treatment outcome through a collaboration with pediatric leukemia experts, Drs. Karen Rabin (Baylor
University/Texas Children's Hospital) and Charles Mullighan (St Jude Children's Hospital). Finally, murine and
human xenograft pre-clinical in vivo B-ALL platforms to determine the impact of depleting leukemia-supporting
monocytes (anti-CSF1R therapy) in combination with conventional B-ALL chemotherapy on B-ALL survival.
These findings will ultimately provide the basis for clinical trials combining CSF1R inhibition with existing B-ALL
therapeutics. This proposal outlines my career development plan for obtaining the necessary preparation to
transition into a successful independent investigator. My postdoctoral supervisor, Dr. Iannis Aifantis, fully
supports my distinct research program. My ongoing training with experts in nonclassical monocyte biology (Dr.
Hedricks, La Jolla Institute for Immunology), live in vivo two-photon microscopy (David Fooksman, Albert
Einstein) and single-cell bioinformatics (Dr. Tsirigos, NYU Applied Bioinformatics Laboratories) will provide the
essential knowledge to accomplish my long-term scientific goals. Collectively, the proposed research and
career development plans will generate data with a significant impact on immune-based therapies in pediatric
leukemia and provide the basis of my future research as an independent researcher.

Public health relevance
Project Narrative A subset of B-cell acute lymphoblastic leukemia (B-ALL) patients will relapse and succumb to treatment- resistant disease. We found that B-ALL remodels the microenvironment around the leukemia to alter monocyte differentiation, with a subpopulation of nonclassical monocytes that both predicts pediatric and adult B-ALL patient survival and supports B-ALL progression and treatment evasion. The goal of this project is to determine the precise function of leukemia-associated nonclassical monocytes in supporting B-ALL survival and establish new immune-based therapeutic approaches that improve the efficacy of conventional B-ALL therapies, which reflects the public health relevance of this project.